CSHL Advanced Techniques in Molecular Neuroscience (2025 - 2029)

ABSTRACT
CSHL Laboratory Course in Advanced Techniques in Molecular Neuroscience
The proposed Cold Spring Harbor Laboratory (CSHL) course Advanced Techniques in Molecular
Neuroscience (ATMN), to be held annually in July 2025– 2029, is part of the CSHL’s postgraduate training
program in neurobiology. ATMN is a short, intensive sixteen day hands-on course which prepares students to
enter directly into research that makes use of advanced and/or specialized molecular techniques in
contemporary aspects of neurobiological research. Experimental modules in the course will include quantitative
assays of RNAs bound to protein by crosslinking immunoprecipitation (CLIP), translating mRNA isolation from
specified neural subtypes (TRAP), expansion microscopy and tissue clearing methodologies combined with
single RNA molecule detection by hybridization chain reaction (HCR), preparation of pure astrocyte and neural
progenitor cell cultures, design and use of engineered viral vectors in neuroscience research, design and use of
CRISPR/Cas genome editing tools, practical exercises in gene delivery systems in vivo, single cell and nuclei
isolation followed by genome-wide assessment of chromatin state and transcription factor binding by ATACseq
and Cut & Run, and proximity labeling proteomics. Experimental techniques are taught in the context of the
broader conceptual advances that they may provide. We have additionally added several hands-on data analysis
session for single cell and chromatin-based data throughout the course. The course invites lecturers who have
made significant contributions in their fields to give up-to-the-minute reports on current research. The trainees
are chosen by the course faculty from larger pools of applicants and range from graduate students to senior
investigators and research physicians. Because of the short duration of this course, senior, as well as junior
individuals can attend and receive a short, intense period of training in an environment remote from other
demands on their time and attention. The ATMN course also provides an unusual opportunity for established
scientists to apply these advanced techniques to their own research interests, or to retrain in an important
specialty within neuroscience with which they may not be familiar. Methods and concepts taught in the course
are disseminated to the wider research community through the publication of laboratory manuals and online
resources.

Public health relevance
PROJECT NARRATIVE CSHL Laboratory Course in Advanced Techniques in Molecular Neuroscience This application seeks funds to support an advanced neuroscience lab-based short course at Cold Spring Harbor Laboratory, New York. The course aims to provide advanced training in state-of-the-art molecular approaches and concepts in neuroscience. Trainees include advanced graduate students, postdoctoral researchers and young faculty from throughout the United States and abroad. The selection process for entry into these courses is highly competitive, and trainees leave the course armed with new techniques, know-how and potential collaborators to apply to their own areas of research. A significant proportion of trainees subsequently undertake basic or applied research in diseases of mental health and/or neurological disorders. Methods and concepts taught in the course are disseminated to the wider research community through the publication of laboratory manuals and online resources.